Deep Learning Based Pharmacokinetic Model for Vancomycin

Abstract: (30 lines)
Vancomycin is one of the most commonly used antimicrobial drugs in inpatient settings. National guidelines
recommend Bayesian models to monitor the therapeutic drug concentration of vancomycin, especially for
methicillin-resistant Staphylococcus aureus (MRSA), to minimize drug toxicity while maintaining its efficacy.
Existing Bayesian models, despite being claimed as patient-specific pharmacokinetic (PK) models, use simple
patient features and are studied in limited patient populations for the population-based PK parameters (the
Bayesian prior). Increasingly available real-world electronic health records (EHR) provide a wide range of
patient-specific data, including data on vancomycin dosage and serum levels. However, the limited flexibility of
the Bayesian model structure prohibits the full use of these rich data. Deep-learning models, such as recurrent
neural network (RNN), are particularly attractive for PK of vancomycin in EHR, compared to Bayesian models
and other traditional machine learning models, because deep-learning models enable more flexible patient-
specific inputs and possess a higher latent capacity. Thus, they deliver better predictions for a diverse
population. Our deep-learning model for vancomycin (PK-RNN-V) outperforms publicly available Bayesian
models but can be improved on various aspects. In Aim 1, we will improve PK-RNN-V model architectures and
add more patient-specific data and a finer timestep. We will construct two-compartment PK-RNN models to
increase predictive power in patients with unsteady states. We will augment PK-RNN-V with Med-BERT to
improve the embedding of categorical data. We will also develop multi-track ordinary differential equations
models for simultaneous prediction of serum creatinine and vancomycin levels. In Aim 2, we will use EHR from
different sources to validate our PK-RNN-V model and improve the data-extraction flow and pre-processing to
harmonize data from healthcare systems. We will use EHR from Houston Methodist Hospital and Memorial
Hermann Hospital System/The University of Texas Health Science Center in Houston, TX, the University of
Arizona in Phoenix, AZ, and the publicly available MIMIC-IV database (Boston, MA). These databases contain
data from more than 121,007 patients who received at least one dose of intravenous vancomycin. In Aim 3, we
will add dosing recommendations based on PK-RNN-V model predictions as a feature and validate our model
in specific subgroups with challenging vancomycin PK to predict PK levels. This project will deliver substantial
model improvements, leading directly to the optimization of vancomycin use in hospitals, increased in patient
safety by minimizing adverse events, and reduced healthcare costs, which align with NIH’s research mission.

Public health relevance
Project Narrative: (3 sentences) Bayesian models that monitor serum vancomycin levels to optimize the delivery of intravenous vancomycin have limitations in achieving a patient-specific pharmacokinetic model. To overcome these limitations, we will develop deep-learning based models suited for time-sequencing data to disentangle complex relationships in big patient data from electronic health records. The success of our models will lead to optimized vancomycin usage, increased patient safety, and reduced healthcare costs through high prediction accuracy and reliability.